From microcin sequence to function: linking sequence variation to antimicrobial activity

Project Summary
New approaches to antibiotic development are needed to combat multidrug-resistant bacteria, and
especially Gram-negative pathogens. The Gram-negative outer membrane prevents most molecules from
entering the cell and is one of the greatest hurdles to new antibiotic development. A remarkable strategy to
overcome this permeability barrier is shown by the new clinical antibiotic cefiderocol, which binds outer
membrane siderophore receptors and uses active transport systems to pull itself into the periplasm. Using
energy-coupled import allows otherwise exclude molecules, like the antibacterial component of cefiderocol, to
enter bacteria. Unfortunately, few molecules capable of this translocation have been identified, and we have
been largely limited to using siderophore conjugates to develop these innovative Trojan horse antibiotics. Our
work on the understudied class of bacteriocins called microcins provides a rare opportunity to study a broader
class of antibacterials with this membrane translocation ability. Microcins are small antibacterial proteins
(<10kDa) that selectively bind Gram-negative outer membrane proteins and hijack active transport processes to
enter the periplasm. Microcins have are effective at controlling pathogen growth in vivo and have many
characteristics that could make them attractive antibiotic scaffolds. Despite their potential value, advances in
microcin biology have been impeded by the challenges of their identification and the limited characterization of
the only 15 known examples. To overcome the discovery bottleneck, we developed an approach for systematic
identification and validation of new microcins. We have focused our research on class II microcins due to their
prevalence among Gram-negative bacteria. Coupling an in silico pipeline with a new method for microcin activity
screening, we are identifying microcins across phylogenetically diverse bacteria, including phylogroups that have
never been examined for microcin activity. We have already validated over 50 novel class II microcins, which is
5X what has been discovered in the past 40 years. Our new appreciation for class II microcin diversity has made
plain the critical need to develop detailed knowledge of their sequence-activity relationships to empower their
future use in antibiotic development. Foremost among our gaps in knowledge is our lack of understanding of
microcin cell entry and the diversity of receptors that microcins can target. These factors dictate the initial step
required for microcins to cross the outer membrane and are central to controlling microcin spectrum of activity.
To pursue these critical gaps in knowledge, we will take advantage of the large exclusive repertoire of
unrecognized class II microcins we have discovered and will (Aim 1) provide the first in-depth microcin sequence-
activity study to uncover postions import for receptor binding, cell entry, and antibacterial activity, (Aim 2) reveal
how sequence variations among microcins influence their spectrum of activity, and (Aim 3) uncover the range of
outer membrane receptors that can be targeted by microcins for cell entry.

Public health relevance
Project Narrative Microcins have the rare ability to bind Gram-negative bacterial surface proteins and transport themselves across the outer membrane to inhibit essential targets hidden underneath. We lack an understanding of how microcins encode these remarkable abilities in their short protein sequences. We will uncover microcin domains important for each stage of their action and how variations in their surface receptor binding controls their spectrum of activity, which will support the future development of innovative antibiotics.